Violence Across the Lifespan - Opioids Maternal Brain

Project Summary/ Abstract
Violence Across the Lifespan – Opioids Maternal Brain
Peripartum women affected by the fast-growing and devastating epidemic of Opioid use disorder (OUD) in
the US constitute an understudied, underrepresented, and underreported (U3) population of significant public
health importance. OUD, which is associated with violence across the lifespan, manifests withdrawal
symptoms, impaired interpersonal interactions, depression, neonatal abstinence syndrome and higher risks of
child maltreatment. We plan to piggy-back this administrative supplement on our current NIDA R01 DA047336
“Opioids and Maternal Brain-Behavior Adaptation During the Early Postpartum”, which is examining
mechanisms in our corticolimbic maternal behavior neurocircuit (MBN) that regulate parenting behaviors and
may be affected by OUD. The MBN contains brain circuits, that are also established to be affected childhood
trauma and interpersonal violence. For maternal behavior, there are two reciprocally inhibiting subsystems for
(1) care, mediated by the medial preoptic area in the hypothalamus, ventral tegmental area, nucleus
accumbens and ventral pallidum; and (2) defense/aggression, mediated by periaqueductal grey. The MBN
regulates flexible responses to the demands of mother's own infant during the early postpartum period – such
as to the unique, ethologically salient own-baby cry and empathic responses to own infant images. Within the
scope of our R01, this Supplement will examine human maternal brain-behavior in the participant mothers
undergoing Buprenorphine Treatment (BT) for OUD (n=32) as compared to non-OUD depression Matched
Controls (MC, n=32). In the concurrent R01, all participants are already undergoing fMRI scans at ~6 months
month postpartum with measures of resting-state functional connectivity, neural responses to own-baby cry,
and gray matter volumes of MBN. The supplement will allow us to add a “bonus” Child Face Mirror Task
(CFMT) as a neural measure of maternal empathy. We will also add measures of child & recent trauma,
interpersonal violence, social inequality, deprivation, discrimination, and resilience. Thus. with this
interdisciplinary supplement, in answer to NOT-OD-22-031 “Research on the Health of Women of
Understudied, Underrepresented and Underreported (U3) Populations”, we propose specific aims to explore
a mediation model that will (1) examine associations between childhood trauma and current
interpersonal violence, OUD, and MBN dysregulation and (2) examine brain-behavior mechanisms in
maternal social cognition and intersubjectivity, that may be crucial for OUD and infant outcome. We will
also explore the scant knowledge and brain behavior mechanisms on the impact of violence across the
lifespan on the U3 population of pregnant women – with and without OUD. Translational potentials include
better understandings of risk/resilience profiles for mothers with OUD that bear the transgenerational burden of
peripartum drug use and may be exposed to violence.

Public health relevance
Project Narrative Violence Across the Lifespan – Opioids Maternal Brain Peripartum women affected by the fast-growing and devastating epidemic of Opioid use disorder (OUD) in the US constitute an understudied, underrepresented, and underreported (U3) population of significant public health importance given significant comorbid depression, polysubstance use, and neonatal abstinence syndrome with effects on the social emotional brain circuits that govern maternal caregiving thoughts and behaviors that shape infant development - are the subject of our existing NIDA R01 DA047336R01 “Opioids and Maternal Brain-Behavior Adaptation During the Early Postpartum” – but not yet studied with respect to violence across the lifespan. This interdisciplinary supplementary project will extend ongoing multimodal and longitudinal measurements of brain physiology and mother-infant interactions which focuses on buprenorphine treated OUD with comparison groups of depression matched controls, to add measures of childhood trauma and current interpersonal violence to study a mediation model, which will also include health disparity factors indexed by income to need ratio, subjective socioeconomic status, multidimensional deprivation, social vulnerability and in-depth socio-demographic information on the household of familial origin. The completion of this supplement will contribute to the virtually non-existent body of knowledge on the effects of violence across the lifespan on maternal brain behavior mechanisms for to ultimately benefit the families that bear the transgenerational burden of peripartum drug use.